Pathology Core

Pathology Core
Summary
The pathologic analysis of human and animal samples is an integral component for all projects of this P01. The
task of the Pathology Core is to provide well-characterized, high-quality biospecimens as required by the projects
and to ensure that longitudinal, structured, clinical information related to treatment and outcome is collected from
the patient donors of those specimens. The recurring theme of the investigations across the project is the
genomic characterization of biospecimens by multiple high-throughput platforms. This provides an
unprecedented opportunity to cross-validate biologic insights on a genomic scale and should provide a novel
perspective through which to study urothelial carcinogenesis, progression, and resistance to specific treatments.
This Core will serve as a model for addressing the difficult problems associated with cross-investigator and cross-
institutional data exchange by providing a web-based portal that will allow all investigators to browse and query
the contents of the biorepository, de-identified clinical data, and translational research resources such as
Standard Operating Procedures, reagent details, and primary datasets. The Pathology Core will work in close
collaboration with the project investigators to achieve the following specific aims: Aim 1, provide pathologic
review of all tissues used in the P01 project; Aim 2, maintain a urothelial biospecimen repository; Aim 3, provide
professional and technical services for the preparation and quality control of molecular analytes from the
biospecimen repository; and Aim 4, provide all P01 investigators with a common portal for access to and query
of project data. To facilitate seamless coordination, the Core directors will have direct and frequent
communication with the leaders of the P01 projects and Administrative Core, which enables us to serve the
needs of all the P01 projects and to facilitate a highly successful P01 outcome. The Pathology Core will closely
interact with the Bioinformatics Core concerning the design of the projects, pathological analytes, and quality of
the tissue subjected to analytical algorithms. It will receive assistance from the Administrative Core concerning
strategic oversight, regulatory issues, and communication with other projects, cores, and the funding agency.

Public health relevance
Narrative The projects of this P01 will use human bladder cancer specimens and cell lines from urothelial cancer for translational research directed toward improving the detection, prevention, and treatment of human bladder cancer. The Core will provide the investigators at UTMDACC as well as other collaborating institutions with high quality tissue samples from patients with bladder cancer diagnosed, treated, and followed in our institution. Standardized and centralized procedures have been established for tissue procurement, quality control, processing, storage, and distribution of samples to individual investigators, which will ensure optimal utilization of the samples according to the guidelines established by the Tissue Committee and IRB regulations.